Defining the role of perineuronal nets in Alzheimer's Disease pathology

Project Summary
Alzheimer’s Disease (AD) is the most common cause of dementia in elderly populations. The development of
effective treatments for this progressive neurodegenerative disorder has been hindered by our lack of
understanding of the disease. AD is classically characterized by amyloid-β (Aβ) plaques, neurofibrillary tangles,
and brain-wide neuroinflammation which ultimately result in synaptic loss, neuronal dysfunction, and cognitive
impairments. With our incomplete knowledge of the mechanisms underlying the emergence of these pathological
hallmarks, we must focus on understanding the different aspects of disease pathology to successfully create
therapies treating AD. Genome wide association studies (GWAS) have implicated microglia, the tissue-resident
macrophages of the brain, as mediators of disease pathogenesis. Microglia actively maintain tissue homeostasis
in the healthy brain including the regulation of lattice-like extracellular matrix (ECM) structures called
perineuronal nets (PNNs). PNNs enwrap the soma and proximal synapses of different neuronal subsets and aid
in learning/memory consolidation. While PNNs are naturally lost with age in wild-type (WT) mice, this loss is
exacerbated in AD. Interestingly, when microglia are eliminated in the AD transgenic 5xFAD mouse model, 1)
plaques fail to form and 2) PNN loss is prevented, altogether suggesting PNNs play a protective role. However,
the consequences of PNN loss in AD remain unknown. To that end, we have developed two approaches to
ablate PNN structures both before and after the onset of plaque deposition in order to determine their role in
plaque formation, synaptic loss, and neuronal loss. In this proposal, I will determine the impact of PNNs in AD
pathology by pursuing two important questions: 1) does the loss of these ECM structures facilitate plaque
formation and 2) does PNN loss make neurons more susceptible to damage? Collectively, this proposal will
elucidate the role of PNNs in AD – before and after the onset of plaque pathology – by exploring how their
experimental ablation will affect plaque deposition, synaptic loss, and neuronal loss. Establishing whether PNNs
can prevent plaque deposition as well as determining whether PNN loss in AD renders neurons more susceptible
to damage is highly relevant and could lead to new therapeutic avenues that target genes/ proteins involved in
PNN synthesis and degradation.

Public health relevance
Project Narrative Alzheimer’s Disease (AD) is a progressive neurodegenerative disorder resulting in dementia primarily in the elderly populations. The age-dependent increasing plaque load in AD has been correlated with an exacerbated loss of extracellular matrix structures called perineuronal nets (PNNs). Thus, it is imperative we determine the consequences of PNN loss in AD to gain deeper insight into pathology progression as well as the therapeutic potential PNNs may hold.